FY24-FY33 NIAID-DLA Pharmaceutical Vendor Program

The NIAID-DLA IAA enables DAIT/ NIAID to purchase brand name pharmaceutical products (ie: biologics) at a significantly discounted (50-60% cheaper) price for use in NIAID-supported clinical trials.